EFFECTS OF BLOOD ALCOHOL ON DRIVING SIMULATION PERFORMANCE

Healthy college males whose diet, exercise, and rest has been controlled will be tested on driving simulation and neuropsychological tests after administration of either an alcoholic or nonalcoholic drink. Will determine how blood alcohol affects cognitive/motor functioning and operations of an automobile and how accurately individual can judge impairments.